Dissection of NTSR2/calcium channel signaling as a non-opioid spinal analgesic mechanism for the treatment of high impact chronic pain

Project Summary:
Spinal administration of analgesics such as opioids and local anesthetics via an implanted intrathecal drug
delivery system have profound efficacy in some of the most severe high impact chronic pain conditions. Despite
their profound efficacy, their use is limited primarily because of side effects such as tolerance, psychosis and
motor block associated with drugs used in them (opioids, ziconotide, local anesthetics). Novel analgesics that
take advantage of spinal pain processing, are safe to use in humans and have minimal motor block and tolerance
can be revolutionary in the management of high impact chronic pain conditions.
Contulakin-G (CGX) is a snail venom derived peptide that has homology with mammalian neurotensin has been
shown to be safe in humans and in a small, pilot Phase1A study demonstrated analgesic effects in patients with
spinal cord injury pain, a high impact chronic pain condition. These studies suggested a possibility of a novel,
non-opioid, analgesic mechanism that is active in humans. Our preliminary studies in animal models of high
impact chronic pain unraveled spinal neurotensin receptor 2 (NTSR2) and subsequent inhibition of voltage-gated
calcium channels Cav2.3 and 2.2 as an opioid-independent spinal analgesic mechanism. Importantly, despite
profound analgesia, NTSR2 activation was not associated with unwarranted side effects such as rapid tolerance
or motor blockade.
Despite clear translational relevance of NTSR2-Cav2.3/2.2 pathway, nothing is known about NTSR2
downstream signaling that leads to calcium channel inhibition, particularly so in sensory neurons. Aim 1 will
evaluate detailed signaling following NTSR2 activation that leads to calcium channel inhibition in mouse sensory
neurons. Aim 2 will assess the anatomical correlation and functional significance of NTSR2-Cav pathway in
human sensory neurons and spinal cord. Aim 3 will evaluate in vivo significance of this pathway in models of
high impact chronic pain with rigorous independent replication.
If successful, proposed studies could unravel the signaling molecules involved in human-tested mechanism for
the treatment of high impact chronic pain conditions. Moreover, this information can be utilized for further
development of novel analgesics that are biased agonist of or directly engage this signaling pathway.

Public health relevance
Project Narrative: Spinal analgesics have profound efficacy in high impact chronic pain conditions as they directly target the spinal dorsal horn, a critical center in the pain processing. However, their widespread use is encumbered due to the limitations of clinically available spinal analgesics. Here, we propose a comprehensive study of a non-opioid/ nonlocal anesthetic spinal analgesic pathway unraveled by mechanistic studies of a human tested molecule.